The medaka Kiyosu panel: dissecting GxE effects of environmental chemicals

Abstract
Environmental pollutants (contaminants) have a profound impact on human health leading
to in utero congenital defects, early childhood development defects and the incidence and
progression of chronic adult disease. As well as being a major contributor to health burden overall,
the heterogeneous distribution of environmental contaminants leads to health disparities between
different groups. However, environmental exposures have a variable impact on individuals, and
a substantial part of that variation is due to genetic effects. By studying these “Gene x
Environment” (GxE) effects, one can both quantify phenotypic changes and importantly gain
mechanistic, molecular understanding of the biological pathways involved in contaminant
responses. This understanding in turn can inform both treatment and policy in environmental
health. To make a step change in our understanding of GxE interactions, we have assembled an
international, multi-disciplinary team to exploit a unique resource, the wild-derived inbred Kiyosu
panel of medaka (Japanese rice-paddy) fish. This panel is formed from 111 inbred lines from a
single population (captured near the town of Kiyosu), inbred to near-homozygosity and each
genome sequenced. In this proposal, we seek to screen 10 environmental contaminants (chosen
for their impact and chemical diversity) on multiple early developmental, high dimensional,
quantitative measurements on heart physiology, heart development and skeletal development.
The Kiyosu panel brings together the best features of both the Mouse Collaborative Cross (CC)
and the Drosophila Reference Genome Panel. Similar to the CC, the Kiyosu panel is in a model
vertebrate with a broad range of genetics capabilities. However, a critique of the CC is the relative
lack of founding genetic diversity, and that the diversity of the founders is not representative of a
wild population. Here the Kiyosu panel is similar to the DRGP being derived from a single diverse
wild population and capturing the majority of its genetic diversity. Preliminary data demonstrate
reproducible GxE effects of selected chemicals on heartbeat phenotypes in a subset of medaka
lines, and careful statistical power analysis provides confidence that we can map individual loci
using a directed F2 cross strategy. The high dimensional phenotypes can be exploited using
modern, scalable multi-trait techniques. Having discovered individual GxE loci underlying
differential contaminant response in this vertebrate, we will molecularly characterize the loci using
in depth phenotyping, CRISPR genetic tools, and RNAseq. All data and results will be made
openly available to the community, and the panel can be accessed via an open MTA. We will also
integrate the information with other killifish environmental models (Fundulus heteroclitus), the
Mouse (Collaborative Cross), and human (UK BioBank, ALSPAC) resources to exploit this
information with the community and translate insights to a human context.

Public health relevance
Project Narrative Using a unique and innovative wild-derived inbred panel of a model fish, Medaka, we will comprehensively discover GxE components of 10 environmental contaminants. We will map these GxE effects to single loci, and characterise the mechanisms underlying the GxE environmental contaminant responses.